Data-Driven Mathematical and Computational Modeling of Hepatitis D Infection and Treatment Response

Hepatitis delta virus (HDV) is an infectious subviral agent that can propagate in individuals
infected with hepatitis B virus (HBV). It is the most severe form of chronic viral hepatitis in humans
and ~20 million people worldwide are estimated to be chronically infected. In the U.S., the
prevalence of chronic HDV infection is rising with recent data suggesting an urgent need for
screening and treatment. There is no FDA approved treatment for HDV with current therapy
consisting of pegylated interferon-alpha which only achieves cure in ~25% of patients. With limited
treatment data available, understanding the dynamics of HDV infection and treatment response
is in its infancy. The new prenylation inhibitor lonafarnib is the first direct acting anti-HDV agent
being tested clinically, but pegylated interferon-lambda, Nucleic acid polymers and HDV/HBV
entry inhibitor myrcludex B are also being investigated as anti-HDV therapies providing ongoing
opportunities characterize HDV treatment dynamics and the mechanism of action of HDV
antivirals and provide a window into the dynamics among HDV, HBV and host during co-infection.
To gain insights into HDV-HBV-host-drug dynamics we have established an interdisciplinary team
that includes clinicians who perform HDV treatment clinical trials, experimentalists to perform
treatment and HDV/HBV coinfection studies in humanized mouse models and mathematical
modelers to create mathematical/computational models to explain the patient and mouse data.
The long-term goal of this proposal is to determine the MOA of anti-HDV drugs and optimal use
of antiviral agents for the treatment of HDV.

Public health relevance
Hepatitis delta virus (HDV) is the most severe form of chronic viral hepatitis. While there are currently no approved therapies for HDV, both interferon- and interferon-λ, and other clinically relevant therapeutics such as nucleic acid polymers, myrcludex B, and a new prenylation inhibitor, lonafarnib, are being investigated as anti-HDV treatments. Using kinetic data from clinical trials and novel humanized mouse models of HDV and hepatitis B virus (HBV) infections, we propose to develop new mathematical models to elucidate the dynamics of HDV-HBV-host infection and treatment response in order to determine how to effectively treat HDV.